A novel role for higher order auditory circuits: social group dynamics and descending pathways to the Social Behavior Network

Project Summary/Abstract
Healthy social group living relies heavily on the ability to process complex sensory environments. In several
prevalent neurological and neuropsychiatric disorders, deficits in social interactions are frequently associated
with pathology in auditory circuits. Broad lesions of higher auditory circuits result in alterations in social behavior.
Despite a strong connection between auditory cognition and social behavior, we lack basic knowledge about
how higher auditory circuits influence social group dynamics. The long-term goal of this proposal is to provide
enhanced training that will enable the applicant to establish mechanisms by which higher auditory circuits support
integration into social groups at behavioral and neural levels. Aims in this proposal will test the extent to which
higher auditory pathways are critical for social group living through investigation of their role in complex group
dynamics and their neural circuit outputs to social behavior brain areas. In the K99 phase, Aim 1 will test the
extent to which specific damage to the pathway between primary and secondary auditory pallium (caudomedial
nidoapllium, NCM) modifies approach and avoidance behavior in pair bonds and small groups of animals during
social group formation. Preliminary data demonstrate that descending neural pathways from higher auditory
areas modify social auditory processing in a social behavior nucleus, the lateral ventromedial nucleus of the
hypothalamus (VMHl). Thus, Aim 2 will test the extent to which electrophysiological signatures of auditory
memory (which is critical during social interactions) are represented in higher auditory NCM versus social
behavior nucleus VMHl. During the mentored phase and in completion of the above Aims, the applicant will
receive, in addition to novel conceptual training, comprehensive training implementing viral-mediated genetic
ablation of neural pathways, automated behavioral analysis of complex social group dynamics, social network
analysis, and multi-site in vivo electrophysiological recordings. In the R00 independent phase, the applicant will
leverage this training to advance a research program that expands from study of single brain regions to
synaptically-connected networks, and from individual behavior to large social group dynamics. Aims 3 & 4 will
move forward to test the roles of descending pathways in the speed of integration into large social groups, and
test the hypothesis that VMHl uses higher auditory circuit input to evaluate competing motivations (i.e., make
decisions to engage in social versus non-social behaviors). The innovative approach of this proposal comes from
the intersection of technical and conceptual advances in systems neuroscience, behavioral neuroendocrinology,
and behavioral ecology using a highly gregarious study species, zebra finches, that constantly dissect complex
auditory environments in large social groups. Expanding basic knowledge of mechanisms by which higher
auditory pathways impact social group living can provide a critical foundation for future design of treatments for
social symptoms of neurological and neuropsychiatric disorders.

Public health relevance
Project Narrative Social deficits and/or isolation are often accompanied by pathology involving higher auditory circuits in a variety of prevalent neurological and neuropsychiatric disorders. This strong link between auditory cognition and social behavior across disorders suggests that higher order auditory circuits are essential to healthy social group living, but basic knowledge about how these neural systems interact is lacking. The proposed research will explore the intersection of auditory and social circuits in the control of social group dynamics in order to deepen understanding of dysregulation of auditory-guided social behaviors.